Georgia Department of Agriculture - Laboratory Flexible Funding Model (LFFM) Project

Project Summary / Abstract
The purpose of this proposal is to improve the capacity and capability of our state laboratory to
analyze human food and animal feed products in support of an integrated food safety system
(IFSS). The Georgia Department of Agriculture’s (GDA) Laboratory Division will work toward this
goal by submitting this application for funding of a cooperative agreement through the Laboratory
Flexible Funding Model (LFFM), specifically Project A1: Microbiology Human Food Product
Testing, Project A3: Microbiology Animal Food Product, Project A7: Microbiology Method
Development/Validation, Project A8: Microbiology Capacity/Capability Development, Project B1:
Chemistry Human Food Testing, Project B2: Chemistry Animal Food Testing, Project B3:
Chemistry Food Defense, Project B4: Chemistry Method Development/Validation, and Project B5:
Chemistry Capacity/Capability Development.
This cooperative agreement will provide the funds needed to GDA’s Laboratory Division which will
enable the maintenance of current ISO/IEC 17025 accreditations, expand upon analytical analysis
with the intent of increasing the scope of accreditation, collect and analyze risk-based samples
while contributing to regulatory activities. These funds will support federal MFRPS and AFRPS
contracts, as well as enhance collaboration between our State Regulatory Program (SRP)
partners and the Laboratory for a stronger integrated food safety system. To achieve this goal,
GDA will collect and analyze food and feed samples for the adulteration substances in FDA
regulated products, as well as participate in method development and capacity/capability
enhancement projects.

Public health relevance
Georgia Department of Agriculture Overall – Project Narrative Project Period: July 1, 2025 – June 30, 2030 Project Narrative Georgia Department of Agriculture (GDA) will continue its efforts to progress toward a national integrated food safety system (IFSS) by maintaining compliance with the Manufactured Food Regulatory Program Standards (MFRPS), Preventive Control (PC) rules, and with Animal Food Regulatory Program Standards (AFRPS). The GDA Laboratory will accomplish this by continuing to be the primary servicing laboratory for GDA regulatory programs, for maintaining ISO/IEC 17025 accreditation, and by collecting samples for the analysis of contamination or fraud in order to protect consumers. Award of this grant ensures that the State of Georgia moves forward in maintaining, developing, and enhancing the best practices to support IFSS. Sustained ISO/IEC 17025 accreditation for regulatory laboratory testing coupled with robust sampling programs requires significant resources. Ultimately partnerships with FDA and project funding such as the Laboratory Flexible Funding Model (LFFM) for the Georgia Department of Agriculture will support IFSS to protect the public from foodborne illness.